Establishing culture conditions for uncultured microbes

PROJECT SUMMARY
Microbes play crucial roles in human health. They contribute as pathogens, as sources of enzymes and bioactive
compounds, and through their roles in the communities that make up the microbiome which impacts numerous
diseases and physiological processes. Cultivating microbes in isolation is a key step for understanding their
biology and utilizing their products. Culture allows controlled manipulations, genetic perturbations, analysis of
metabolites, and testing interactions with the host and other microbes. However, it is currently difficult to establish
culture conditions for uncultured microbes, and many important microbes have not yet been cultured in isolation.
Recent advances in the field have made this challenge more tractable, and here we propose to unlock the study
and utilization of uncultured microbes by establishing their growth conditions. This work builds on the PIs
background in microbiology and microfluidics, especially utilizing two recent contributions: the “SPOTs” liquid
handling platform, which allows high-throughput, high-performance liquid handling with unprecedented ease;
and a scalable pipeline for 16S genotyping which allows cost effective parallel processing of samples for high-
throughput sequencing. This work will be focused on two related projects. In the first project we seek to establish
the first axenic culture of the intracellular bacteria Wolbachia, from order Rickettsiales. Wolbachia is prevalent in
insects and nematodes playing a key role in and filarial diseases and the spread of viral diseases through insect
vectors. To culture Wolbachia, we will generate many thousands of diverse media compositions using the SPOTs
platform then monitor cell metabolic activity with redox active dyes and cell division with microscopy to determine
which conditions are most favorable. Iteratively we incorporate data from each experimental cycle to refine the
media compositions until they can support growth. Axenic Wolbachia growth would be a major advance that may
also unlock culture of additional organisms from Rickettsiales, of which there are dozens of important uncultured
pathogens. In the second project we will utilize a “many-by-many” strategy, generating many diverse medias,
using SPOTs, to simultaneously grow many different microbes from different starting communities including fecal
and soil samples. Growth will be monitored by microscopy and which organisms grow in which media
compositions will be determined using our high throughput 16S genotyping method. We expect that this approach
will culture a wide range of yet-uncultured organisms, enabling their characterization and use and providing a
rich dataset linking different microbes to the conditions in which they grow. The impacts of this work include
catalyzing the study and use of new microbes by determining their culture conditions and contributing a powerful
new approach for addressing combinatorial questions in biomedicine.

Public health relevance
PROJECT NARRATIVE Growing microbes in culture is crucial for both studying them and harnessing their potential across myriad contexts in human health, but culture conditions remain elusive for many important organisms. This proposal seeks to grow yet-uncultured organisms, including Wolbachia and diverse species from the microbiome and soils. Completion of this work will unlock in-depth study and applications for new organisms while also advancing an approach to establish microbial culture conditions.